CORE B – PROTEINS & ASSAYS

CORE B – PROTEINS & ASSAYS
ABSTRACT
The APOBEC3 (A3) family of single-stranded DNA-cytosine deaminases function normally to defend cells
from invading viruses. Overwhelming evidence implicates at least two of these family members, APOBEC3A
(A3A) and APOBEC3B (A3B), in causing mutagenesis in a wide variety of primary cancers, with metastases
frequently showing increased mutation burdens attributable to these enzymes. Over the previous funding period,
this Core successfully developed protein expression methods capable of producing up to milligram quantities of
highly active A3 enzymes and identified custom antibodies (in-house and in collaboration with industry) that are
specific to both A3A and A3B and useful for a wide variety of assays including immunoblot, IHC,
immunofluorescent imaging, and ELISA. In addition, this Core has developed novel assays for determining the
activity of A3 enzymes and has performed these assays to support the scientific activities of the Program. Here,
Core B – Proteins & Assays will continue to support the Program through two specific aims. Aim 1 will continue
to produce essential proteins including A3 enzymes and anti-A3 monoclonal antibodies for use by Program
members, Program collaborators, and the broader scientific community. Aim 2 will continue to perform
standardized activity and binding assays for Program members and collaborators, and additionally, develop new
assays and standard operating procedures (SOPs) for use by Program members and the broader scientific
community to ensure inter-lab reproducibility. The availability of these standardized reagents and assays will
enable the Projects and Cores to continue to advance the overall goal of blocking A3A/B-dependent tumor
evolution. Rigor and reproducibility are enhanced by having a single Core produce standardized reagents and
perform key assays for each of the Projects and other Cores, while additionally reducing the overall cost by
centralizing these essential services.

Public health relevance
CORE B – PROTEINS & ASSAYS NARRATIVE APOBEC3A and APOBEC3B are DNA-mutating enzymes that are now widely recognized to be causing mutations in cancer. The unifying hypothesis of this Program is that inhibition of these APOBEC3 proteins will serve to complement cancer therapy by reducing mutations that lead to drug resistance and metastasis. Core B – Proteins & Assays will produce enzymes, antibodies, and other proteins necessary to accomplish Program goals as well as develop and perform assays as a service to the Projects and Cores.